Role of lncRNA Meg3 in obesity-induced endothelial senescence and insulin resistance

PROJECT SUMMARY
Obesity-induced insulin resistance is a risk factor for diabetes and cardiovascular disease. To identify new
targets for insulin-sensitizing therapies, better understanding of the currently elusive mechanisms behind
obesity-induced insulin resistance is needed. Cell senescence is a stable form of cell cycle arrest characterized
by several hallmarks, including mitochondrial dysfunction, DNA damage, and senescence-associated secretory
phenotype. While cell senescence can exert beneficial effects in human health and disease, it plays a causative
role in the pathogenesis of obesity and associated vascular complications. However, the mechanisms underlying
endothelial senescence in obesity and how it impacts obesity-induced insulin resistance remain poorly
understood. Long non-coding RNAs (lncRNAs) are a subgroup of non-protein coding RNA transcripts that
regulate gene expression in a range of signaling pathways, and changes in their expression and function
contribute to the pathogenesis of human diseases. To identify lncRNAs that regulate obesity-associated
endothelial senescence, transcriptome analysis of mouse vascular endothelium revealed that maternally
expressed gene 3 (Meg3) is a top differentially expressed lncRNA upon metabolic stress. Meg3 knockdown
causes endothelial senescence in vitro and in obese mice, which is associated with impaired mitochondrial
homeostasis and function, and an increase in mitochondrial superoxide. In obese mice, Meg3 knockdown
impairs hepatic insulin signaling and induces systemic glucose and insulin intolerance. This preliminary work
also identified matrin-3 as a new binding partner of Meg3. Matrin-3 is a DNA- and RNA-binding protein linked to
the development of neurodegenerative disorder in humans, a disease closely associated with cardiovascular
disease. Matrin-3 knockdown induces oxidative stress and endothelial senescence in vitro. The expression of
either Meg3 or matrin-3 positively correlates with the expression of cyclin-dependent kinase inhibitor p16 (an in
vivo marker of senescence) in human liver specimens. These observations led to the central hypothesis that
endothelial cell senescence contributes to obesity-induced insulin resistance, which is controlled by Meg3 and
matrin-3 through the regulation of mitochondrial function. Aim 1 will test the hypothesis that Meg3 and matrin-3
are critical regulators of mitochondrial function in endothelial cells. Aim 2 will determine the role of Meg3 and
matrin-3 in endothelial senescence and paracrine function. Aim 3 will test the hypothesis that endothelial
senescence contributes to obesity-induced insulin resistance. This project will uncover new roles of Meg3 and
matrin-3 in regulating obesity-induced cell senescence in vascular endothelium and their effects on insulin
resistance, contributing to the long-term objective to develop more effective therapies for endothelial
senescence-related complications of obesity, diabetes, and cardiovascular disease.

Public health relevance
Project Narrative More than one-third of U.S. adults are obese, predisposing many of these individuals to insulin resistance, a risk factor for diabetes and cardiovascular disease. This project will investigate how Meg3 and matrin-3 regulate endothelial senescence in obesity by regulating mitochondrial integrity and function, and how obesity-induced senescence in vascular endothelium contributes to insulin resistance in obesity. By completing these studies, this project will identify new targets for developing therapeutic approaches to improve insulin sensitivity in obese individuals, which will have important clinical benefits for obesity, diabetes, and cardiovascular disease.